Microscopy & Enteroids

Project Summary - Core B - Microscopy and Enteroids (Prasad and Estes)
The role of the Microscopy and Enteroid Core is to provide a centralized facility to serve the electron microscopy
(EM), fluorescence microscopy, and enteroid culture requirements of all of the investigators in the Program
Project. This integrated Core is cost-effective and facilitates orderly and efficient use of resources to complete
the proposed projects in a timely fashion. In addition, the use of the core allows for consistency and quality
control across all projects. The specific functions of the Core, as required routinely by the three projects, will
include: (1) Specimen preparation for EM and fluorescent microscopy, including epifluorescence, confocal, and
deconvolution microscopy; (2) EM imaging of fecal samples from norovirus-infected persons, virus-like
recombinant particles (VLPs), VLP-carbohydrate, VLP-antibody complexes, virus produced from infected
cultures, full-length p41 oligomers, and empty and p41-reconstituted nanodiscs; (3) EM imaging of stained and
fixed thin sections of virus-infected cells to assess cell binding and replication; (4) Evaluation of purity, particle
integrity, and concentration and suitability of samples for cryo-EM imaging and computer reconstructions; (5)
Immune electron microscopy using gold labels; (6) Data acquisition, interpretation, sharing, and archiving from
the EM, fluorescent, confocal and deconvolution microscope imaging; (7) Scheduling and day-to-day EM
maintenance of EM, epifluorescence, confocal and deconvolution microscopes; (8) Cultivation and providing
media and well-characterized human intestinal enteroid (HIE) cultures to all Projects; (9) Preparation and
characterization of genetically modified enteroid lines for all Projects; and (10) Preparation and characterization
of biosensor-expressing HIE lines to monitor infection or host cell processes. Core key personnel will interface
with program project group leaders and other investigators to meet the microscopy and enteroid requirements
of all Projects. Overall, the microscopy and enteroid core is a key component of success of the program project
and will provide critical resources, enhance communication and comparability of results between different
projects.